Noninvasive biomarkers for gastrointestinal disease in preterm infants

PROJECT SUMMARY
Our objective is to develop a clinically-usable test that can diagnose gastrointestinal disease early in infants.
Initially described nearly 200 years ago, necrotizing enterocolitis (NEC) is the most frequent gastrointestinal
disorder in preterm infants. It affects 7-12% of preterm infants born with very low birth weight (< 1.5 kg).
Thus, nearly 6,000 preterm infants per year suffer from this bowel disease and an average total in-hospital
treatment is $500,000 per infant. NEC is a lethal disease, due to delayed diagnosis: nearly 30% of infants who
contract NEC die and median time to death is 1 day after x-ray imaging of free air in the intestine. Since NEC
is not diagnosed with high specificity or in a timely fashion, survivors of surgical intervention are faced with
long-term complications, such as shortened gut, nutritional deficiency, and neurodevelopmental delays. In
sum, infants afflicted with NEC incur $5 billion in US medical care annually. Our value proposition is that early
and accurate diagnosis would decrease the number of infant deaths, prevent long-term health challenges of
survivors, and lower the economic expense of the disease. Such a model has three requirements to fulfill its
commercialization promise. First, early detection of disease is actionable. Second, as prematurity is a health
inequity, the method of testing is universally accessible regardless of resources, easy to adopt, and can
integrate in current medical workflows. Third, disease delineation in patients, who are asymptomatic or
present confounding general symptoms, opens new opportunities for therapeutic development and
personalizing treatment for each patient. To achieve this, the initial barrier is elucidation of molecular
characteristics, or biomarkers, that intersect with dysbiosis, human metabolism, and inflammatory responses
of NEC. Our maiden biomarker, NECDetect, provides direct readout of an individual human’s ability to
modulate gut homeostasis. For this application, we address unique technical, logistic, and regulatory
challenges for NECDetect. To do so, we have assembled a multidisciplinary team of discovery scientists,
clinicians, biomarker assay developers, and regulatory consultants. Project aims encompass kit prototype
development, sample collection, assay validation, and sample analysis for regulatory evaluation. End goals
are predictive disease segmentation of infants using the NECDetect prototype and reference values in the
neonatal population.

Public health relevance
Necrotizing enterocolitis (NEC) affects 6,000 premature American infants each year. For infants with NEC, more than a third die. Following advanced stages of NEC, survivors end up with disabilities and a diminished quality of life. A biomarker that improves diagnosis of the disease will lower mortality and life-long health complications. The non-invasive formats are necessary for fragile neonates, can be integrated in existing pathology lab workflows, reduce length of hospital stay and decrease healthcare costs.